Ubiquitin pathway modulators as novel antituberculosis drugs

New approaches are needed to treat NIAID priority pathogens, including Mycobacterium tuberculosis (Mtb).
Emerging drug-resistance in Mtb poses a significant threat to global health, generating a pressing need to
develop innovative therapeutics with the potential to avoid the rapid evolution of drug resistance. One novel
approach is to harness host defense mechanisms to treat both drug-sensitive and drug-resistant tuberculosis
(TB). A key observation that may lead to new combination therapies is that we have identified important roles for
autophagy (ATG) proteins in resistance to Mtb specifically via degradative autophagy killing the organism. These
new findings, in the setting of the extreme medical need for new approaches to treat TB, led to this new SBIR
application to fully leverage prior discoveries and to focus on TB and multidrug-resistant (MDR)-TB in response
to NIH and public health priorities. As a master regulator of autophagic degradation of mitochondria, Parkin E3
ligase is an important protective factor against Mtb. Parkin E3 ligase promotes clearance of Mtb in macrophage
infection models. As such, activation of Parkin is expected to have antituberculosis therapeutic effect. Pogenra’s
UbiProTM drug discovery platform was employed to discover novel, potent and selective Parkin activators. We
demonstrated that Parkin activators robustly inhibited growth of Mtb in macrophages. In this Phase I grant, we
propose evaluate Parkin activators for their antimycobacterial efficacy in cellular and animal models of
tuberculosis and perform mechanism of action studies. The ultimate commercial goal of this project is the
development of small molecule Parkin activators as novel drugs that could treat tuberculosis.

Public health relevance
Tuberculosis (TB) caused by Mycobacterium tuberculosis (Mtb) is the leading cause of death by a single pathogen. Currently, the first line therapies require longer duration (6-18 months), has toxic side effects and are prone to emergence of drug-resistance. Emerging drug-resistance in Mtb poses a significant threat to global health, generating a pressing need to develop innovative therapeutics with the potential to avoid the rapid evolution of drug resistance. One novel approach is to harness host defense mechanisms to treat both drug- sensitive and drug-resistant tuberculosis (TB). Studies in model organisms and human genetics strongly support a crucial role for the autophagy machinery in restricting the replication and virulence of Mtb. This application proposes to develop potent and selective E3 ligase activators as novel antimycobacterial agents.